Assay for Inhibitors of HSD17b4, hydroxysteroid (17-beta) dehydrogenase

this project aims to identify small molecule inhibitors of the enzyme to potentially serve as therapies for these implicated diseases. The collaborative team worked previously to validate and characterize hits of interest from the previous HSD17b4 screen. During this period, the team continued with validation work on the previously identified hits, and is currently pursuing medicinal chemistry optimization of the most promising hit scaffolds. As a center, the NCGC has fostered and maintained over 110 active collaborations with both NIH and extramural investigators, facilitating drug discovery efforts across the entire spectrum of human disease. These efforts have led to dozens of high-throughput screens and a number of medicinal chemistry campaigns to further improve on screening hits, providing our collaborators and the general research community with publications and a variety of promising small molecule probes and leads. In addition, the NCGC has worked to advance a number of informatic initiatives to make better use of existing drug and disease target information and provide the general public with easily accessible resources, further catalyzing the development of new therapies for human disease.